Microscopy and Animal Phenotyping

Resource/Service Core: Microscopy and Animal Phenotyping Module
Abstract
The Microscopy and Animal Phenotyping Module will continue to provide equipment, infrastructural support,
expertise, and technical assistance to vision scientists in order to enable detailed, quantitative imaging of cells
and tissues, as well as equipment and support for structural and functional assessment of the visual system in
vivo. This state-of-the-art facility includes several pieces of high-end hardware for image and data collection,
dedicated analysis workstations, and the expertise needed to support and enhance ongoing research and
explore new research questions posed by vision scientists. Facility operations will include: 1) maintaining and
servicing the equipment, 2) managing usage of the equipment, 3) educating investigators on the capabilities of
the equipment, 4) advising investigators on the design of imaging experiments for vision research projects, 5)
providing training on the proper usage of the equipment, and 6) helping researchers collect, process and
analyze high quality microscopy and visual function data for both current and future applications.
The specific services and technologies provided within the Microscopy and Animal Phenotyping Facility are:
a) cell and tissue processing, labeling, and immunocytochemistry,
b) light and fluorescent microscopy,
c) laser scanning confocal microscopy,
d) multiphoton microscopy and time-lapse imaging,
e) slit lamp imaging and in vivo confocal microscopy,
f) optical coherence tomography (OCT), angiography, autofluorescence imaging (BAF), infrared
imaging (IR), and fundus imaging,
g) electroretinography (ERG/PERG/VEP),
h) behavioral testing (optokinetic response, looming object, and pupillometry), and
i) quantitative image and data analysis.
Overall, the Microscopy and Animal Phenotyping Module will support a range of imaging technologies for
participating investigators, and facilitate easy access to equipment, training and technical support that will
expand experimental capabilities, open up new research directions, and result in more cost-effective, time-
efficient, and rigorous imaging studies. An additional goal is to facilitate collaborative studies using these
cutting-edge imaging techniques among vision scientists at UTSW and with other outside institutions.